Mechanistic insight into oxidative stress-mediated genome instability

Mechanistic insight into oxidative stress-mediated genomic instability
Parent award: R35GM142982
ABSTRACT
Genome instability is characterized by genetic alterations that include DNA base mutations, chromosome breaks,
rearrangements and instability, hallmarks of various human diseases including cancer. Chromosome instability
(CIN) that results from inaccurate chromosomal segregation, originates from telomere and centromere
dysfunctions. Numerous epidemiologic studies have highlighted the central role of oxidative stress exposures in
the occurrence of telomere and centromere dysfunction. Critically, however, the mechanisms underlying the
dysfunction are not clearly understood. Oxidative stress results from an imbalance between the production of
reactive oxygen species and cellular antioxidant defenses. It arises from endogenous sources as well as from
environmental sources (mitochondria metabolism, UV light, air pollution, cigarette smoke). Its ubiquity highlights
the importance of properly understanding its impacts on human health. A major impact of oxidative stress is the
induction of oxidative DNA damage that are repaired by the base excision repair (BER) pathway in which
poly(ADP-ribose) polymerases (PARPs) are major actors. PARP1 and PARP2 are responsible for the poly(ADP-
ribosyl)ation, a post-translational modification of proteins that modulates the recruitment and interactions of their
protein targets. The goals of this proposal are to (i) uncover the mechanisms of oxidative stress-mediated
genome instability with a focus on its impact on telomeres and centromeres, two genomic loci crucial for genome
stability and (ii) decipher the contribution of PARP enzymes in the protection of telomeric and centromeric DNA
upon oxidative DNA damage. To this end, we are leveraging a unique and innovative chemoptogenetic tool that
induces oxidative DNA damage locally at telomeres and at centromeres without impacting the rest of the
genome. This will allow us to unequivocally link phenotypic changes and PARP dependent mechanisms to the
telomeric or centromeric lesions. These projects aim to fill a long-standing gap of knowledge on how poly(ADP-
ribosyl)ation orchestrates DNA repair at two crucial regions of the genome. They will also shed light on how
oxidative stress, an ubiquitous factor of genome instability, can drive numerous human diseases. Ultimately, our
work will contribute to the development of novel therapeutic strategies targeting specific regions of the genome
and inform the rational design and use of the PARP inhibitors already widely used in cancer treatments.

Public health relevance
Mechanistic insight into oxidative stress-mediated genomic instability Parent award: R35GM142982 NARRATIVE Telomere and centromere dysfunction can occur upon exposure to chronic oxidative stress that triggers DNA damage and genome instability, a hallmark of many human diseases including cancer. This proposal is designed to decipher the mechanisms by which oxidative stress impacts these two genomic loci and delineate the roles played by DNA repair proteins PARPs in their protection. The data collected will ultimately contribute to the design of novel telomere and centromere-centric therapeutic strategies for the treatment of oxidative stress- driven human diseases.